Research Training in Pediatric Oncology

PROJECT SUMMARY/ABSTRACT
This is a competitive renewal application for training grant support in pediatric oncology. The goal of this T32
program is to train physicians who will be the future academic leaders in basic and/or clinical pediatric
oncology research and who will work to reduce the burden of cancer in the pediatric population. To accomplish
this goal we have engaged a diverse and outstanding training faculty that embraces multiple areas of basic
(“wet bench”), translational and clinical research. This experienced and highly accomplished group includes
members of the Department of Pediatric Oncology at the Dana-Farber Cancer Institute (DFCI), the Division of
Pediatric Hematology/Oncology at Boston Children's Hospital (BCH), and additional components of the
Harvard Medical School (HMS). Particular emphasis is placed on close mentorship of trainees in the selection
of mentors and in on-going oversight during their research. The T32 program provides training in oncology
research at the postdoctoral level for 8 trainees, selected from the combined DFCI-BCH pediatric
hematology/oncology fellowship program, who are in their second, third and fourth years of training. These
fellows spend on average five to six years in a protected training environment with limited clinical
responsibilities, and the proposed T32 renewal would continue to support three years of that training. The
program is committed to identifying and supporting the most promising fellows, including minority candidates.
Over the past 45 years the DFCI-BCH fellowship program has trained over 200 individuals, many of whom are
leaders of academic pediatric hematology/oncology programs. Continued T32 support will ensure the training
of investigational pediatric oncologists, whose research will contribute immeasurably to the understanding and
management of childhood cancers.

Public health relevance
PROJECT NARRATIVE While great strides have been made in the diagnosis and treatment of pediatric cancers, much remains to be done. The cure of children with cancer is often achieved with unacceptable side-effects, and for many cancer subtypes of pediatric cancer, current therapy is inadequate. The best hope for reducing the burden of pediatric cancer is the training of committed researchers by an experienced and accomplished faculty that is involved in diverse aspects of basic and clinical research directly relevant to tackling these challenging problems in children.